Screening for small molecule modulators of SCFbTrCP ubiquitin ligase complex

The goal of this project is to identify small molecule modulators of the SCFTrCP complex. SCF E3 ubiquitin ligases are a family of proteins which promote the proteasome-mediated degradation of almost 80% of cellular proteins and play a crucial role in cellular physiology, signaling, and transformation. SCFTrCP is a particularly important member of this family, as it is often deregulated in many types of cancers as well as other diseases.

To date, the project team has optimized a cell-based assay that employs a nanoluciferase degron to monitor specific cellular activity of the SCFTrCP complex. Employing this assay, we have completed initial screening of our drug repurposing libraries and have a peer-reviewed manuscript summarizing this work under review. We have also expanded screening of our internal collections and are developing an SCF counterassay to support hit triage.